Changing the Landscape of Soil Transmitted Helminth Infections in India Using a One Health Approach

PROJECT SUMMARY
Soil transmitted helminths (STH) - hookworms (Ancylostoma duodenale and Necator americanus),
Ascaris lumbricoides and Trichuris trichiura - are among the most widespread neglected tropical diseases
(NTD) of humans worldwide, disproportionately affecting the poorest and most vulnerable communities. In
rural, populations, intensive animal-human mixing with livestock and companion animals combined with poor
hygiene and sanitation can lead to transmission of zoonotic infections as well as result in zoonotic sources
of infection. It is estimated that 30% of households globally have domestic livestock animals, with south and
southeast Asia and Africa contributing the largest proportion. These regions also have the highest burden of
STH globally. Most epidemiological surveys and mathematical models of STH do not account for or measure
the risk of infections acquired from zoonotic sources, either by direct contact with animals or animal feces or
indirectly from the environment. The inability to interrupt transmission due to presence of zoonotic and
environmental reservoirs of infection may prolong mass drug administration (MDA) campaigns and result in
emergence of anthelmintic resistance.
The overarching goal of this multi-disciplinary collaborative application is to use a One Health
framework to examine the interconnected burden and transmission patterns between human, animal and
environmental reservoirs of STH by integrating carefully collected epidemiological, environmental and
qualitative research data with state-of-art molecular techniques to better inform monitoring and elimination
strategies in endemic communities. We will leverage an ongoing randomized controlled trial on community
wide MDA and an upcoming One Health project in two eco-epidemiologically and culturally distinct
geographic regions of India (Tamil Nadu and Meghalaya) to: (1) comprehensively investigate the
transmission dynamics of different STH species at individual, household and community levels; (2) ascertain
the impact of community wide MDA on zoonotic STH transmission and screen for emergence of
benzimidazole resistance markers; and (3) develop and validate field-ready, portable point-of-collection
(POC) diagnostics for STH based on prevalent human and zoonotic species. The field and laboratory data
will provide the key parameters to build species-specific STH transmission models and explore the impact of
human, animal and environmental reservoirs on STH control measures, across a range of transmission
scenarios. The One Health framework of this TMRC will provide much needed data for future planning of
integrated STH control programs that combine community wide MDA with upgraded WASH, supported by
POC molecular diagnostics. The center will provide a platform for early career investigators to conduct multi-
disciplinary One Health research on STH as well as other zoonotic or helminth NTDs.

Public health relevance
PROJECT NARRATIVE Soil transmitted helminths (STH) are a major public health problem worldwide, disproportionately affecting the poorest and most vulnerable communities. Intensive animal-human mixing with livestock and companion animals combined with poor hygiene and sanitation in these communities can lead to transmission of zoonotic infections as well as result in zoonotic sources of infections. Most epidemiological surveys and mathematical models of STH do not account for or measure the risk of infections acquired from zoonotic sources either by direct contact with animals or animal feces or indirectly from the environment. Our program aims to use a One Health framework to examine the interconnectedness between human, animal and environmental reservoirs of STH by integrating epidemiological, environmental and qualitative research data with state-of- art molecular techniques into species-specific transmission models to better inform monitoring and elimination strategies for this neglected tropical disease.